Carolina Population Center Administrative Core

The Administrative Core plays a key role in organizing, monitoring, and fine-tuning the activities
of the Center. This core works closely with Development and Research Services Cores to make
sure that services are provided efficiently, that efforts are not duplicated, that junior scientists
have the support they need to establish and maintain a successful research agenda, and that
senior scientists can carry out complex interdisciplinary population science projects in the US
and elsewhere. The Core’s activities fall into three basic areas: planning and implementation of
activities that create and maintain a stimulating intellectual community that advances the
science in our primary research areas, streamlining administrative processes related to
research administration so that scientists can focus on research, and coordinating, evaluating,
and communicating about activities of the Cores and Center overall. Part of the Core’s work is
to evaluate services we provide, assess the need for services we don’t provide, and plan for
how to introduce them. An efficient, cost-effective, customer-centric Administrative Core plays a
pivotal role in the overall success of our Center. When all facets of the Center function smoothly
and efficiently, faculty know that the support exists to pursue research ideas that are creative,
complicated, and cutting edge—that they can do so without being encumbered by routine
administrative tasks that divert time and effort from research and writing. The confidence that
such support exists is fundamental if projects are to realize their full potential to advance
science.